IGF::OT::IGF : NIH PAIN CONSORTIUM CENTERS OF EXCELLENCE IN PAIN EDUCATION. JULY 15, 2015 - JULY 14, 2016. N01DA-15-4430.

UCSF will develop content to be used for the creation of online interactive case-based learning tools. UCSF will implement the learning tools in its learning environment, assess its materials, and disseminate the findings from this assessment. Further, UCSF intends to collaborate with other CoEPEs and entities with the goal of promoting improved pain education.